National Health Literacy Mapping to Inform Healthcare Policy

DESCRIPTION (provided by applicant): Our study objective is to provide valid estimates of health literacy for every census block group in the U.S. and demonstrate the value of such a health literacy measure for informing healthcare research, policy and practice. Health literacy, or one's ability to obtain process and understand information needed to make health decisions, is considered not only a reflection of an individual's skills and abilities, but also how well health systems provide information and services. This concept therefore serves as an indicator of the quality, equity, and safety of public health and healthcare. Unlike many other indicators, however, health literacy is considered modifiable. Interventions utilizing health literacy 'best practices' have been shown to lead to improved health outcomes. Despite its promise, health literacy has rarely been included in policymaking. Health literacy is one of the most important, independent risk factors for hospital readmission. Strategies that incorporate health literacy principles have successfully reduced readmissions. This is particularly significant as the Centers for Medicaid & Medicare Services (CMS) recently began penalizing hospitals with adjusted readmission rates above the national average for acute myocardial infarction (AMI), heart failure (HF) and pneumonia. To date, the adjusted rates used by CMS include only medical comorbidity and age. While the purpose of the penalties is to promote quality of care and reduce costs, the lack of adjustment for health literacy places an undue burden on hospitals that serve patients who are at greatest risk for low health literacy and are more likely to struggle with self care activities. Adjusting for health literacy would ensure that penalties are fair and identify hospitals in greatest need of health literacy-informed initiatives. Through this study, we will demonstrate that a derived health literacy measure can be estimated for each of the 217,740 census block groups in the U.S. using the RAND predictive model. By linking health literacy estimates to a national cohort of ~300,000 Medicare beneficiaries, we will demonstrate the predictive strength of the estimate. We will then link the health literacy estimates to a national cohort of ~176,000 Medicare patients with AMI to examine the impact of health literacy on hospital readmissions for AMI. Finally, we will we will use the health literacy estimates to augment the CMS analytical models (clinical profiling shrinkage estimation and risk-adjustment) of adjusted AMI readmission rates. Our specific aims are to: 1a) Estimate and map the average health literacy score of each census block group in the United States, 1b) Examine the relationship between health literacy estimates and a composite of clinical endpoint outcomes (mortality, HF, AMI, stroke, end-stage renal disease) among ~300,000 Medicare beneficiaries, 2) Investigate the impact of health literacy estimates on 30-day readmission among a national cohort of ~176,000 Medicare patients with AMI and 3) Compare the risk standardized readmission rates with and without adjustment for the derived health literacy score among the national Medicare AMI cohort for hospitals across the United States.

Public health relevance
PUBLIC HEALTH RELEVANCE: Despite being a recognized risk factor for poor health outcomes, health literacy is often inadequately accounted for in public health and healthcare policy. To advance the field, a comprehensive method of measuring health literacy at a population-level is needed. We will provide valid estimates of health literacy for every census block group in the U.S. and will then demonstrate the value of these measures for informing research and national healthcare policies to improve health outcomes in the elderly with high risk.